Administrative Core

Core A: Administrative Core: (Diamond Director) The Administrative Core will provide administrative and secretarial support for all activities of the Center. Dr. Diamond as Director of the Program will supervise this Core. Ms. Sylvia Jones will be administrative assistant for the Program funded by the Feinstein Institute as tangible evidence of the Institute's commitment to the Program. The Administrative Core will provide administrative and secretarial support for all four projects and for the Histology, Behavior and Monoclonal Antibody Cores. Ms. Jones will oversee budgets, organize work-in progress meetings, and assist with manuscript preparation. The Administrative Core will organize a once-a-year symposium and review of the entire Program by the Advisory Committee. The Core will be available to support and promote in any way necessary the research agenda of the Program.